Epidemiology and Long-Term Effect of Cardiometabolic Medication Substitution during Post-acute Care

PROJECT SUMMARY/ABSTRACT
Nearly 70% of older adults experience medication discrepancy–inconsistencies in medication regimens when
they transition from acute hospital to skilled nursing facilities (SNF). Medication discrepancy in this period often
results from inadequate reconciliation processes and formulary or financial restrictions in hospitals or SNFs.
Medication discrepancy can take the various forms, including omission, addition, duplication, and substitution.
Among these types, substitution accounts for up to 20% and frequently involves cardiovascular medications.
Clinical observations suggest that newer, high-cost cardiometabolic medications (e.g., angiotensin receptor
neprilysin inhibitor, sodium-glucose cotransporter 2 inhibitors, and glucagon-like peptide 1 receptor agonists) are
often substituted with less expensive and less efficacious alternatives in SNFs. Such substitutions may impact
chronic disease outcomes if the modified regimen is continued after SNF stay. Despite the common occurrence
of medication substitution during SNF stays and its potential clinical significance, systematic investigation has
been hindered by the lack of a comprehensive database containing medication administration records from a
large number of SNFs. The objective of this study is to determine the epidemiology and clinical consequences
of cardiometabolic medication substitution in SNF. The investigators’ hypothesis is that persistent medication
substitution beyond SNF stay is associated with worse outcomes compared with no substitution or resolved
substitution during SNF stay. To test this hypothesis, they will use the Long-Term Care Data Cooperative platform,
which provides electronic health records data from nationwide SNFs linked with Medicare data. The specific
aims are: 1) to determine the frequency and factors associated with cardiometabolic medication substitution
during post-acute SNF stay among older adults after elective orthopedic surgery; and 2) to determine long-term
chronic disease outcomes associated with cardiometabolic medication substitution during post-acute SNF stay.
The project is innovative because it is the first national-scale study of medication substitution during the post-
acute SNF stay. The impact of this research is significant because the evidence generated from this research
can enable optimal medication management of cardiometabolic conditions in the transitional period. Moreover,
the GEMSSTAR award will provide mentorship, training, and experience for the Principal Investigator to emerge
as a leader in optimizing medication use for older adults.

Public health relevance
PROJECT NARRATIVE This proposed research aims to investigate the prevalence of cardiometabolic medication substitution and its potential long-term health outcomes among older adults in the transition from acute hospitals to skilled nursing facilities (SNFs). Leveraging a novel nationwide SNF electronic health record linked to Medicare data will provide a comprehensive investigation of this prevalent practice. The evidence generated from this work can offer better guidance for clinicians and healthcare systems on safe medication management within post-acute care settings.